GENETIC SCREENING OF FAMILIES WITH NONINSULIN DEPENDENT DIABETES MELLITUS

The complex genetics of NIDDM have so far hindered the identification of its etiology. We plan to identify over 300 affected sibling-pairs with NIDDM to obtain family, demographic, physical exam and historical information as well as a single blood sample of genomic DNA. By utilizing PCR technology, the entire genome will subsequently be screened for loci associated with NIDDM in sibpairs.